Measuring Well-Being and Its MultidimensionalDeterminants Across Individuals and the Life Course

RESEARCH PLAN – Summary/Abstract
This project develops and applies methods to compare the overall personal well-being of different individuals using
answers to survey questions asking respondents to rate many aspects of well-being. Comparing well-being across
individuals and groups is a crucial input to many scientific endeavors: (1) using cross-sectional data to study the
determinants of well-being or to study changes in well-being over the life course, (2) studying inequality in well-being,
which in turn is necessary for aggregating personal well-being into a measure of social welfare, and (3) quantifying the
extent of group advantage or disadvantage when nonmarket goods are taken into account.
Two key issues arise in comparing overall personal well-being between individuals (or groups): first, different individuals
may use the reporting scale differently; second, being able to compare any pair of individuals A and B requires being able
to make an assessment of who has higher overall personal well-being when A has a higher level of some aspects of well-
being, but B has a higher level of other aspects of well-being.
Specific Aim 1 addresses scale-use differences: Develop and validate methods to compare the levels of self-reported
aspects of well-being, such as emotions, pain, and perceived capabilities in daily life, across individuals and across
groups in a way that adjusts for systematic differences in response styles and self-report biases.
Specific Aim 2 addresses the question of how to deal with comparisons when one individual has higher levels of some
aspects of well-being, while the other individual has higher levels of other aspects of well-being: Develop the theoretical
foundation for a new interpersonally-comparable well-being measure, consistent with the equivalence approach in
welfare theory, and adapted to use empirically with multidimensional subjective well-being measures (in
conjunction with the scale-use-correction methods in Specific Aim 1).
Specific Aim 3 involves data collection, empirical analysis, and theory to apply these methods to studying changes in
well-being over time and over the life course: To better understand the patterns of, and reasons for, the movement of
different aspects of well-being over the life course, collect two waves of highly multi-dimensional data on self-
reported aspects of well-being along with questions for scale-use correction (see Specific Aim 1), on a survey that
provides a rich trove of complementary data. Develop a theoretical framework for these measures in an economic
model of life-cycle behavior that includes a wide variety of activities, investment decisions, and life circumstances.
Apply the data in this framework to test new and existing theories about the determinants of well-being over the
life course, why existing research finds a mid-life trough in the levels of many aspects of well-being, and how to
distinguish permanent from transitory inequality in well-being.

Public health relevance
The concept of overall well-being provides an important perspective for thinking about public health. Within the study of well-being, assessing which individuals have higher well-being and which individuals have lower well-being is crucial in order to use cross-sectional data to study the determinants of well-being and in order to study inequality in well-being. This project develops methods for comparing overall well-being across individuals even when individuals differ in how they use response scales and well-being has many aspects, and uses those methods to study how well-being varies across individuals and over time, including how it varies across different stages of life.